2019 Staphylococcal Diseases GRC/GRS

Project Summary The purpose of this grant submission is to request funds to partially support the 2019 Staphylococcal Diseases Gordon Research Conference (GRC) and its associated Gordon Research Seminar (GRS). This will be the 16th GRC, with the first being held in 1989 and thereafter on a bi-annual basis. Importantly, it will be the 4th meeting of the GRS, the purpose of which is to foster development of the next generation of staphylococcal investigators and invite their active participation and integration into the broader research community. These meetings will be held at the Rey Don Jaime Grand Hotel, Castelldefels, Spain, with the GRS being held on August 3-4 and the GRC following on August 4-9, 2019. This will be the first meeting at this new GRC site, and consistent with the approach of the Staphylococcal Diseases Gordon Research Conference, is alternating location with the US to encourage participation of a wide array of staphylococcal biologists from around the world. The Chairs for the 2019 meeting will be Drs. Andreas Peschel and Ross Fitzgerald who served as Co-Vice Chairs for the last GRC meeting in 2017 at Waterville Valley, NH. Drs. Alexander Horswill and Julie Bubeck Wardenburg will serve as Co-Chairs for the 2019 meeting, then will Chair the following meeting in 2021. Amy Richards and Simon Heilbronner will serve as Co-Chairs of the GRS. The overall goal of the GRC and its associated GRS is to bring the world’s leading scientists and the most promising young investigators and trainees together in a collegial and supportive environment. The specific goals are to: 1) provide a forum for the presentation of unpublished, cutting- edge research on the staphylococci and foster formal and informal discussions on how these results advance the field, 2) include investigators and clinicians focusing on diverse staphylococcal species and define the impact of these species on staphylococcal infection in both humans and animals, 3) expand the boundaries of the work of the scientists within this filed, and 4) ensure development and integration of young investigators into the broader research community in a meaningful and interactive way. The collegial atmosphere will include organized discussion sessions and opportunities for informal gatherings in the afternoons and evenings, providing an ideal setting for scientists from different disciplines to exchange ideas and foster cross-disciplinary collaborations both among themselves and the next generation of staphylococcal investigators. Thus, the GRC will provide a unique and fundamentally important opportunity to bring together the world’s leading staphylococcal investigators in a format designed for the free exchange of research results and ideas covering all aspects of staphylococcal biology and its relationship to disease. Together with the GRS, the GRC will promote the development of promising young investigators in the field and their integration into the larger research community. In the short term, this will significantly enhance the ability of investigators around the world to address critical problems in staphylococcal disease, while in the long term it will ensure the continued success of their efforts and those of the next generation of investigators.

Public health relevance
Project Narrative The appearance of Staphylococcus aureus isolates resistant to even “last resort” antibiotics like vancomycin, linezolid, and daptomycin raises the possibility of strains resistant to all available antibiotics; in short, a return to the devastation of the pre-antibiotic era. Developments in antimicrobial resistance, epidemiology, pathogenesis, treatment, and prevention of staphylococcal infections are occurring at a rapid pace from an increasingly international community of investigators, and it is imperative to provide these investigators, and the trainees who will ultimately make up the next generation of investigators, with a forum for the open and free exchange of ideas. This is the purpose of the Gordon Research Conference on Staphylococcal Diseases and its associated Gordon Research Seminar.